Epithelial responses to rotavirus induced purinergic signaling

PROJECT SUMMARY
Pediatric diarrheal diseases are a major cause of morbidity in children under 5 years old. Rotavirus is an enteric
virus that causes diarrhea and vomiting and can be fatal in children without supportive care. Rotavirus infection
results in 128,500 deaths per year. Despite causing severe, potentially life-threatening diarrhea, rotavirus
infection is highly localized to the enterocytes in the villus tips of the small intestine. Until recently, it was unclear
how these cell-cell signals were propagated from infected cells to surrounding uninfected cells. Using high
resolution live imaging, we found that rotavirus infection increases calcium (Ca2+) signaling both within infected
enterocytes as well as surrounding uninfected cells, which manifests as intercellular Ca2+ waves. These Ca2+
waves originate from the infected cell and propagate through uninfected cells. We have identified that Ca2+ waves
are mediated by extracellular purinergic signaling; primarily through the purine nucleotide ADP and the P2Y1
receptor. However, the functional consequence of these intercellular Ca2+ waves remains unknown. Our central
hypothesis is that rotavirus-induced paracrine signaling, via P2Y1 purinergic signaling, functionally
dysregulates neighboring uninfected epithelium response and is required for the hallmarks of rotavirus
infection. Potential downstream targets of P2Y1 signaling include chloride (Cl-) and mucin secretion. Rotavirus
infection is characterized by both Cl- driven secretory diarrhea and loss of mucin-filled goblet cells; hallmarks
which are considered to promote infection. We are focusing on rotavirus-epithelial interactions as these events
may be able to mediate the major consequence of infection. The objective of this research is to elucidate the
role of purinergic signaling in host intestinal epithelial cells in response to rotavirus infection and the mechanistic
consequences of rotavirus dysregulation of these pathways. Aim 1 will determine the role of purinergic signaling
via P2Y1 during rotavirus infection in vivo. We anticipate deficiency of P2Y1, by genetic loss of P2Y1 (P2Y1-/-
mice) or inhibition of P2Y1 with the pharmacological inhibitor MRS2500, will reduce rotavirus symptoms including
decreased diarrhea, weight loss, histopathology and cytokine production, and viral shedding. In Aim 2 we will
characterize the signaling pathways in vitro that drive epithelial functions (cell susceptibility, Cl- secretion, and
mucus expulsion) during rotavirus infection in human intestinal enteroids (HIEs). We predict that pretreatment of
HIEs with ADP or P2Y1 agonist increases susceptibility to infection and results in increased infected cells, apical
Cl- secretion and fluid secretion. We anticipate ADP activation of P2Y1 stimulations Ca2+ activated chloride
channels (CaCC) via PLC and IP3R, which also plays a role in mucin secretion from goblet cells. We will use
fluorescent reporters, pharmacological inhibitors and P2Y1 and P2Y2 CRISPR knockout HIEs to identify these
epithelial signaling cascades. This study will provide the first evidence for purinergic signaling in epithelial cells
in the context of rotavirus infection. Collectively, these experiments will enhance our knowledge of rotavirus
pathophysiology and may provide insight for novel therapeutic targets.

Public health relevance
PROJECT NARRATIVE Infectious diarrheal diseases, like rotavirus, cause life-threatening dehydration and are a major cause of morbidity and mortality in children. Despite the introduction of vaccines and use of oral rehydration therapy, rotavirus remains a substantial global health burden and studies investigating rotavirus-induced host paracrine and purinergic signaling has been largely overlooked. This proposal seeks to elucidate the molecular mechanisms and dysregulation of host intestinal epithelial response during rotavirus infection with the aim to identifying potential targets for therapeutics and improved vaccines.